2025 Metabolomics and Human Health Gordon Research Conference and Gordon Research Seminar

Abstract
We are requesting support for the 2025 Gordon Research Conference (GRC) on Metabolomics and Human
Health: The Interaction Between Humans, Lifestyles and the Environment Viewed Through Metabolism, and
the affiliated Gordon Research Seminar (GRS): Metabolomics and Human Health. The GRC/GRS will be held
entura Beach Marriott, 2055 Harbor Boulevard, Ventura, California, United States.
Our proposed conference brings together world-class metabolomics scientists who are advancing data capture
technologies and developing software for data preprocessing and multi-omics analysis, with clinicians,
epidemiologists, and bench level researchers to
February 1-7, 2025, at the V
share advances, describe challenges, and discuss possible
solutions that support the use of metabolomics in precision medicine, nutrition, exposomics and environmental
health ,
. The proposed speakers and attendees will come with a wide array of skill sets in metabolism
microbiome, genetics, technology advancement, software development, and expertise in pharmacology,
toxicology, biochemistry, nutrition, public health, exposure sciences, bioinformatics, informatics, health, and
medicine. We have designed a conference (in collaboration with the Gordon Research Conference
management) that will ensure a venue for vigorous formal and informal discussions. We will maximize
opportunities for prominent investigators to interact with junior attendees of the conference, and those new to
the field of metabolomics. Qualified researchers from underrepresented groups, including women, minorities,
and persons with disabilities will be encouraged to attend for engaged learning experiences, and to contribute
their own perspectives to advancing research. We will prioritize funds from the NIH to support the participation
of underrepresented groups. Our proposal will promote the development, and continued involvement, of
qualified researchers from underrepresented groups in the field of metabolomics.
We are very excited about the diverse range of topics that will be covered at our conference, that span
technology and software development, a wide range of disease and therapeutic areas, and will include
perspectives from genetic, lifestyle and environmental exposures that define an individual’s or system’s
metabotype, and their response to intervention.
We expect the GRC/GRS on Metabolomics to continue to be a “go to meeting” for the metabolomics
community (>150 attendees at the first two meetings), and particularly as a meeting that focuses on in
depth interactions among senior and junior investigators.

Public health relevance
Project Narrative M etabolomics is key in human health and disease research to a) providing biomarkers for the early detection and diagnosis of disease, b) providing tools to monitor drug and non-drug related therapeutic and dietary interventions, c) informing mechanistic insights for the development of new intervention strategies, d) informing needs in exposure reduction, and e) determining how metabolic status is related to health outcomes The proposed Gordon Research Conference (GRC) on Metabolomics and Human Health will support the ability of the international community to come together for in depth discussions of exciting new technology advancements, and applications of metabolomics in areas of cancer, maternal and child health, nutrition, aging, exposure sciences, and the development of intervention strategies. d Gordon Research Seminar (GRS) will provide a unique forum for graduate students, postdoctoral scholars, and early career scientists in metabolomics to associated with health disparities. The affiliate exchange ideas and foster collaborations across five days.